Core B: FSH Glycoform Production, Purification, and Analysis

Project Summary/Abstract:
Core B – FSH Glycoform Production, Purification and Analysis
Core B provides critical and requisite reagents, analyses, and expertise to support all of the Projects in fulfilling
their Specific Aims. Specifically, Core B will continue to produce recombinant hFSH glycoforms and mutant hFSH
glycoforms. Procedures have been established to produce milligram quantities of glycoform variants from the
conditioned medium of cultured GH3 cells transfected with the human FSH a and b subunit genes, CGA and
FSHB, respectively, or mutant FSHB genes. Core B will continue to develop transfection systems to improve
mutant hFSH glycoform production to supply hormone to all four Projects. These hFSH variants mimic known
recombinant hypoglycosylated hFSH glycoforms in terms of their actions upon ovarian cells. Core B will continue
to work with Project 4(Bousfield), to generate and assess antibodies that recognize specifically intact hFSH,
hFSH a subunit, as well as individual glycoform b subunits, for use in glycoform isolation and detection. Core B
will provide a variety of cells for use in Project 2(Davis), Project 3(Jonas), and Project 4(Bousfield) to assess
glycoform receptor binding, FSH receptor oligomerization, FSH receptor mediated signal transduction and
glycoform impact upon cell differentiation. Cells to be furnished include KGN cells, a human granulosa cell line
that responds to hFSH stimulation; CHO cells that express the human FSH receptor; and primary porcine
granulosa cells which naturally express the FSH receptor to complete on-going experiments. GH3 and HEK293
cells transfected with hFSH and mutated genes are critical for the production of recombinant hFSH glycoforms.
Core B will provide analysis support for the Projects including: FSH RIA and ELISA to monitor hFSH levels
during FSH glycoform production and in various biological fluids including serum and urine; mouse FSH ELISA
for Project 1(Kumar); FSH and LH receptor binding; progesterone ELISA to monitor hFSH variant impact upon
target cell function; and hFSH variant antigen ELISA for monoclonal antibody screening. Core B will obtain and
develop studies utilizing porcine cumulus oocyte complexes (pCOCs) to assess potential differential activities of
hFSH glycoform variants upon COC expansion and gene expression.